Clonal hematopoiesis in monocytes contributes to HIV-associated neuroinflammation

Summary
Extravasation of inflammatory monocytes across the blood-brain barrier (BBB) in response to human
immunodeficiency virus type-1 (HIV) is a critical event that leads to chronic neuroinflammation, neurologic injury,
and subsequent loss of cognitive abilities in a significantly large number of infected individuals. However, given
the heterogeneity of monocytes that exists in HIV-infected individuals receiving anti-retroviral therapy (ART), it
remains unknown as to whether the neuro-modulatory actions of monocytes are limited to select subset of
monocytes. Directly relevant to the goals of RFA-21-250, our supporting data reveals that the ART-treated HIV-
infected individuals harbor higher numbers of inflammatory monocytes (CD14lowCD16hi) in their circulation.
These cells also exhibit characteristic features of clonal hematopoiesis (CH), such as loss of DNA
methyltransferase 3A (DNMT3A) and Tet methylcytosine dioxygenase 2 (TET2) with concurrent increase in the
expression of janus kinase-2 (Jak2 ; these three gene products, and few others, are often termed as CH drivers).
Interestingly, subsequent experiments in various models suggested that this monocyte subset (1) translocate to
the central nervous system (CNS) in response to ART, in platelet-dependent manner, (2) is neuro-modulatory in
action, and (3) can be expanded following exposure of monocytes to activated platelets and ART. Based on
these findings, we posit that the priming of monocytes by activated platelets potentiates ART-mediated
clonal hematopoiesis in monocytes, leading to HIV-associated neurologic injury. In this model, we propose
that the composite effect of activated platelets and ART results into clonal expansion of inflammatory
(CD14lowCD16hi) monocyte subset with CH, and subsequent demethylation/induction of PSGL-1 gene in them.
Functionally, these events facilitate the transmigration of such monocytes into the perivascular spaces within the
CNS, where these cells differentiate into macrophage phenotype, while retaining CH profile, and contribute to
the neuronal dysfunction. This model then, in full accordance with the available literature, accounts for how
neurologic manifestations are initiated and maintained due to immune-CNS interaction in ART-treated HIV-
infected individuals.

Public health relevance
Narrative This proposal focuses on learning how anti-HIV drugs and small immune cells known as platelets stimulate abnormal changes in monocytes causing small vessel damage in the brain and neurologic illness during HIV infection. This new information regarding how these cells determine the fate of blood vessel walls is expected to improve therapies against brain disease processes in the general population, as well as those affected by HIV infection.